Hypertension, Blood Pressure Targets, and Alzheimer’s Disease and Dementia Risk and Disparities among Nationally Representative US Veterans

ABSTRACT
U.S. veterans are an increasingly racially, ethnically, and geographically diverse group that has a high risk of
Alzheimer's Disease and Related Dementias (ADRD) due to their high prevalence of cardiovascular risk factors
including hypertension and heightened exposure to ADRD risk factors such as traumatic brain injury (TBI),
posttraumatic stress disorder (PTSD), and depression (hereafter, military-related exposures). Although veterans
are understudied in ADRD research, these characteristics make this high-risk population well-suited to improve
understanding of psychosocial and vascular drivers of ADRD risk and disparities. In particular, several lines of
evidence suggest that hypertension is a major dementia risk factor and that antihypertensive treatment may be
a promising strategy for ADRD risk reduction and prevention. Yet, hypertension, its treatment and target goals,
and association with dementia risk all vary by race/ethnicity, geography, and other risk factors, necessitating the
use of large and diverse cohorts to robustly examine these associations within important potentially high-risk
subgroups. The Veterans Health Administration (VHA) provides health care to veterans that in turn is captured
in electronic health records (EHR) stored in a national repository. This rich dataset will enable investigation of
hypertension and ADRD risk, including within subgroups defined by military-related exposures, race/ethnic
groups, and US region. Further, because the VHA is a single-payer healthcare system, we expect treatment
guidelines to be relatively standard across providers, enabling the use of contemporary econometric methods,
such as regression discontinuity designs (RDD), to estimate causal effects of hypertension treatment with
different treatment cutoffs for optimized ADRD risk reduction. Using a sample of 1,415,230 older veterans (mean
age: 66 years; 149,436 from under-represented minority groups; 32,551 women and 1,122,016 with
hypertension), we propose to estimate the association between hypertension and ADRD risk among US veterans
and within race/ethnicity and geographical region subgroups (Aim 1) and then assess if military-related
exposures (e.g., TBI, PTSD, depression) modify this association, overall and within subgroups (Aim 2). We will
then estimate hypertension treatment effects on ADRD risk using a regression discontinuity design and different
treatment targets and assess if this varies by subgroup and military-related exposures (Aim 3a). Finally, we will
quantify the reduction in ADRD cases that could be achieved at different treatment targets (Aim 3b). This
innovative study will provide multiple public health relevant estimates for the relationship of hypertension,
treatment targets, and ADRD risk. By also examining these associations within subgroups of race/ethnicity,
region, and presence of military-related exposures, this study will enable identification and prioritization of groups
at highest risk of ADRD. As we proposed to investigate several key modifiable risk factors (e.g., hypertension,
depression, PTSD) that occur, not only among veterans, but among members of the US general population as
well, our findings could have broad-reaching implications for ADRD prevention and reduction.

Public health relevance
Project Narrative U.S. veterans are an increasingly racially/ethnically and geographically diverse population that may be at increased risk of Alzheimer's Disease and Related Dementias (ADRD) due to their high prevalence of cardiovascular risk factors such as hypertension and heightened exposure to ADRD risk factors such as traumatic brain injury, posttraumatic stress disorder and depression (military-related exposures). The relationships between hypertension, blood pressure targets, and ADRD risk within potential high-risk subgroups are not well understood, but an integrated nationwide healthcare system like the Veterans Health Administration (VHA) provides a unique opportunity to rigorously examine these relationships in a large, national, and increasingly diverse population. In this study, we leverage VHA data to estimate the association of hypertension and ADRD risk, assess how military-related exposures influence this relationship, and estimate hypertension treatment effects at various treatment targets for optimized reduction in ADRD burden.